Is inhibiting pili electrical conductivity a new anti-virulence strategy?

Project Summary
Adhesion of bacteria to host cells is an essential step in the initiation of an infection, and yet, the
mechanisms that make bacteria sticky are not fully understood. A long list of human pathogens, including
Pseudomonas aeruginosa in the lungs of cystic fibrosis patients, become anchored to host cells using thin (<10
nm), long (>1 µm), and mechanically strong (capable of withstanding pN to nN forces) filaments called pili.
The pili latch onto surfaces through receptor-ligand interactions, and only very recently discovered,
extracellular electron transfer. Bacteria with more electrically conductive pili tend to be more adhesive. By
elucidating the mechanistic basis for this observation, we seek to establish design rules for manipulating
microbe-host interactions for therapeutic purposes. New therapies that inhibit pili-mediated charge transfer
could be realized to block the formation of biofilms by pathogenic species, or to correct imbalances in the
populations of adhered intestinal tract microbiota.
To realize these possibilities, we specifically aim to establish the relative contributions of mechanical
and electrical mechanisms in bacterial adhesion mediated by pili. Alchemical and steered molecular dynamics
simulations will be used to assess the change in stability and tensile strength of pili as a function of point
mutations associated with differently adherent bacteria. A quantum mechanical/molecular mechanical
implementation of Marcus theory, combined with a kinetic model, will be used to compute the electrical
conductivity of different pili. The pili will feature mutations according to a direct electronic modulation
strategy: Standard residues will be replaced with substituent-bearing unnatural counterparts that have similar
steric but different electronic properties. The obtained structure-function insights will drive the second aim of
our research to rationally design and evaluate pili antagonists. Fragment dissolved molecular dynamics will be
used to identify prospective binding sites, into which ligands will be docked in a high throughput screen and
optimized by free energy perturbation techniques.
The work will be undertaken at Yale University under the mentorship of Professor Nikhil S. Malvankar
of the Microbial Science Institute within the Molecular Biophysics and Biochemistry department, and in
collaboration with John Randolph Huffman Professor Victor S. Batista of the Chemistry department. Their
combined expertise with bacterial nanowires (Dr. Malvankar) and the theoretical modeling of interfacial
electron transfer processes (Dr. Batista) will serve as unique assists for the success of the project. The
fellowship training plan involves publishing in high impact journals and presenting at conferences for the
biomedical and chemistry communities. It also includes the opportunity to mentor graduate students. The
career development plan includes attending professional development workshops organized by the Office of
Postdoctoral Affairs, as well as courses relevant to the project.

Public health relevance
Project Narrative Eighty percent of persistent infections are attributed to biofilms, microbial communities that adhere to host cells and confer enhanced antibiotic resistance. These dangerous infections could be prevented if we understood, at a molecular level, the mechanisms bacteria use to adhere to surfaces. In the proposed research, I will establish design principles for manipulating pathogen-host interactions, and rationally design anti- microbial compounds to disrupt bacterial adhesion.